Defining the role of glucocorticoid-related dendritic spine plasticity in cocaine-induced habits

Project Summary
Goal-directed action refers to the ability to select an action based on a desired outcome. In contrast to goal-
directed actions, habits are stimulus-elicited and insensitive to goals. Both goal-directed action and habits are
important for survival, but habits can be maladaptive and are characteristic of many neuropsychiatric diseases
including cocaine use disorder (CUD). The first report that cocaine causes a bias towards habits at the expense
of goal-directed action in rodents was published ~15 years ago, but the underlying mechanisms remain unclear.
Cocaine causes the release of stress hormones, and both cocaine and stress hormone exposure cause the
destabilization of dendritic spines in the orbitofrontal cortex (OFC). Research in rodents also indicates that local
infusion of drugs that destabilize dendritic spines in the OFC disrupts goal-directed action, causing a bias towards
habitual behavior. The investigator will test the hypothesis that chronic cocaine exposure causes habit
biases by increasing levels of circulating stress hormones, activating glucocorticoid receptors (GR),
leading to dendritic spine loss in the OFC. The investigator will thus identify mechanisms by which cocaine
induces habit biases.
In Aim 1, the investigator will use in vivo viral-mediated gene silencing and a task termed “instrumental
contingency degradation”, which tests the ability of mice to associate a trained response with its likely outcome.
The investigator will thereby determine whether cocaine degrades goal-directed action (causing habit biases)
via prolonged stimulation of GRs in the OFC. The investigator hypothesizes that prolonged cocaine exposure
induces habits by triggering CORT release, causing chronic activation of GRs in the OFC. Thus, reducing GR
levels in the OFC will protect against cocaine-induced habitual behavior.
In Aim 2, the investigator will use pharmacological techniques to directly manipulate the actin cytoskeleton
selectively within the OFC to determine the role of cytoskeletal stability in OFC-dependent goal-directed action.
The investigator hypothesizes that stimulating dendritic spinogenesis will promote goal-directed action in
cocaine-exposed mice, while destabilizing dendritic spines will block this effect.
It is widely accepted that psychostimulants and stress modify dendrite and dendritic spine densities and
morphologies, yet causal relationships with the behavioral effects of drugs of abuse or stressors are largely not
verified. Thus, by carrying out this proposed work, the investigator will address fundamental unanswered
questions regarding how stress hormones and dendritic spine plasticity influence the manner in which cocaine
alters complex decision making. This research is highly translational and could reveal new approaches to treating
CUD, for which no pharmacotherapies currently exist, while also equipping the investigator with the skills
necessary for a successful scientific career.

Public health relevance
Project Narrative Considerable evidence suggests that cocaine disrupts adaptive decision making, but the mechanisms underlying this effect are unknown. The proposed experiments will investigate the interaction between cocaine and the stress hormone, corticosterone, in biasing organisms towards habitual behavior with the goal of revealing new approaches to treat cocaine use disorder.